IP23-006 VIMP: A Discourse-Aware, Community-Informed Toolkit to Predict Virality and Impact of Vaccine Misinformation Contents

Project Title:
VIMP: A Discourse-Aware, Community-Informed Toolkit to Predict Virality and Impact of Vaccine
Misinformation Contents
Project Abstract:
We will develop a contextually grounded natural language processing (NLP) model and build a toolkit
around it to leverage the befit of latest developments in data analytics, network simulations and NLP for
increasing vaccine acceptance, vaccination rates and disseminating accurate scientific messages
according to community needs. Our final product, VIMP, will be a discourse-aware, community-informed
toolkit to predict virality and impact of vaccine misinformation contents. We will use a variety of
contextually grounded NLP techniques to design our prediction models and will leverage the benefit of
advanced simulation techniques for model training and evaluation. Our team will also engage with a
diverse panel of community partners who provide advice on model development and tool building. CDC
and its partners could use the tool to rapidly respond to misinformation about vaccines. The model and
tool would further increase CDC's and its partners' ability to prioritize which misinformation content to
respond to and how to allocate resources at the community level.

Public health relevance
Project narrative not required per RFA-IP-23-006.